Optimization of anesthetic/sedative regimen for pulmonary pathophysiology in cystic fibrosis patients

Project Summary
The median age for survival of cystic fibrosis (CF) patients is still in the mid 40s and pulmonary deterioration is
the major cause of mortality for CF patients. Because respiratory exacerbation can worsen the course of their
respiratory status in an irreversible manner, mitigating any complications is critical to improve their quality of
life and life span. CF patients present to surgery and other procedures at various stages of their lives and
frequently experience respiratory complications. Neutrophil-mediated lung inflammation associated with
colonized bacteria and mechanical ventilation-induced injury are considered as important factors contributing
to perioperative pulmonary complications. Flagellin is a primary stimulant of lung tissue by Pseudomonas
aeruginosa, a major colonized strain in CF airway. Flagellin stimulation induces recruitment of activated
neutrophils and causes lung injury. Neutrophil activation is also involved in the lung injury by mechanical
ventilation. Our preliminary study showed that volatile anesthetics attenuated Toll like receptor (TLR)5 and
flagellin-mediated lung injury in the mouse model. The result suggested that volatile anesthetics might
attenuate lung injury caused by colonized bacteria in CF patients. General anesthesia is frequently required for
surgery and other procedures and provided by volatile and intravenous anesthetics. We and others have
shown that volatile anesthetics are immunomodulatory. Our preliminary data suggested that volatile
anesthetics could hinder TLR5 activation in immunocompetent subjects. We previously showed that volatile
anesthetics also attenuated adhesion molecule β2 integrins. Our preliminary data suggested that β2 integrins
were involved in ventilation-induced lung injury. This study aims to test our hypothesis that in CF volatile
anesthetics would attenuate 1) Pseudomonas aeruginosa-mediated lung injury and 2) mechanical ventilation-
induced lung injury using CF transgenic mice and patients’ lung. This will be studied under two Aims:
(Aim 1) Determine the role of anesthetic drugs on pulmonary function in a CF preclinical model in vivo
(Aim 2) Determine the role of anesthetic drugs on lung slice cultures using CF lung tissue ex vivo.
Upon the successful completion of the proposal, we will do clinical study to determine the optimal anesthetic
regimen for people with CF. Because all the drugs tested are in clinical use, we expect that clinical translation
is quite feasible. In addition, we plan to develop new drugs that attenuate lung injury but are devoid of
anesthetic effects using volatile anesthetics as a prototype for general use in CF patients. In addition, this
study is critical because we will assess the effect of anesthetics in immunocompromised setting, which is
important information from clinical standpoint, but has not been tested yet.

Public health relevance
Project Narrative The median age for survival of cystic fibrosis (CF) patients is still in the mid 40s and pulmonary deterioration is the major cause of mortality. They undergo surgical procedures at various stages of their life and often experience respiratory complications, which can lead to pulmonary exacerbation and irreversible damage. Based on our preliminary data and previous investigations, we will test the hypothesis that in CF, volatile anesthetics would attenuate 1) Pseudomonas aeruginosa-mediated lung injury and 2) mechanical ventilation- induced lung injury using CF transgenic mice and CF patients’ lung.